MARC U-STAR PROGRAM AT WASHINGTON UNIVERSITY IN ST. LOUIS

Project Summary
The Washington University MARC U-STAR Program seeks to be part of a larger national effort that promotes
diversity in scientific research and the scientific workforce. Teams composed of individuals from diverse
backgrounds typically outperform teams composed of individuals from similar backgrounds. For the United
States to remain the worldwide leader in research, it must realize the tremendous scientific potential inherent
within its diverse population, much of which currently lies untapped within the underrepresented and
underserved communities. By focusing on research, scientific presentation, and community, our program seeks
to unlock this scientific potential, and in doing so help change the face of the next generation of scientists.
This application requests funds to support ten trainees in our MARC Program. By driving excellence and
innovation in research-based education, our program's mission is to help underrepresented students
succeed in the lab and classroom, matriculate into top PhD and MD/PhD programs, and excel in them. We
focus on three goals to achieve this mission: to provide students top-notch research experiences; to train
them to think critically and to write and speak effectively about science; and to create a positive, personal,
and critical scientific community in which they thrive. We center our program around the research experience
and have developed ten activities that span the two-year, junior- and senior-level program and seek to create a
supportive community in which students obtain rigorous training in research and scientific presentation via
individualized training and critique.
Our MARC Program, which was created in 2008, occupies a unique educational niche within Washington
University. It is the only program that supports underrepresented students during both the academic year and
summer to carry out research. It also incorporates a university-funded, Pre-MARC summer research program
for students who just completed their first-year in college to allow them to experience research, often for the first
time, and to help recruit these students into the MARC Program at the end of their sophomore year. Positive
student feedback on the MARC program illustrates its importance in driving student success and developing a
community in which underrepresented students thrive, with a recent surge in student applications leading to a
quadrupling in program size made possible through additional financial support from diverse university sources.

Public health relevance
Project Narrative: Teams with diverse perspectives outperform those with more limited perspective. Programs that promote a diverse scientific workforce are the essential to continue the tradition of scientific excellence in the United States. This proposal seeks funding for an undergraduate research program that enables students from underrepresented backgrounds to carry out research and participate in academic and professional development events during their junior and senior years. These activities will prepare students to gain entry into and excel in PhD and MD/PhD programs nationwide, empowering the United States to remain the world-wide leaders in scientific research.